Louisiana Clinical and Translational Science Center - N3C supplement

Project Summary/Abstract
The Louisiana Clinical and Translational Science (LA CaTS) Center is a consortium of the major academic
and biomedical research centers in the State of Louisiana. Pennington Biomedical Research Center is the
lead institution and will continue to partner with Louisiana State University Health (LSUH)-New Orleans
and Tulane University Health Sciences Center in this initiative. LSUH-Shreveport, LSU-A&M (Baton
Rouge), Xavier University and Children's Hospital New Orleans, were early Research Partners in cycle 1.
Southeast Louisiana Veterans Healthcare System, a newly opened University Medical Center in New
Orleans ($1 billion State investment), Ochsner Health and the LSUH-NO School of Dentistry joined during
cycle 2. The LA CaTS Center is growing a unified clinical translational science program for Louisiana
based on the creation of synergistic programs and unparalleled collaboration from all the major
academic and biomedical research institutions in the state. Since inception 9 years ago, the LA CaTS
Center has: 1) successfully leveraged resources and expertise of multiple participating institutions to
build a vibrant statewide research infrastructure; 2) developed highly synergistic and integrative
collaborative programs; 3) implemented a systematic approach to clinical research across all institutions,
that includes a new SMART IRB Reliance Model review; and 4) implemented a highly effective
governance system based on an unprecedented level of trust between partners. LA CaTS is experiencing
exponential growth in research productivity as assessed by key metrics including a three-fold increase in
external grant awards, a more than two-fold increase in publications with authors acknowledging LA
CaTS Center resources and services and over 600 researchers benefiting from and using our services.
Notably, during a period that has been marked by unique and unprecedented challenges from COVID
and then Hurricane Ida, LA CaTS has achieved, and in many cases exceeded, its stated objectives and
projected milestones. Indeed, since the COVID pandemic hit Louisiana in March of 2020, LA CaTS has led
multiple successful grant applications for Administrative Supplements and NOSI awards, notably to
facilitate COVID testing and vaccinations in underserved Black communities through the RADx-UP
program and most recently our partnership with the IDeA state ISCORE consortium on the national
Long-COVID initiative - Post-Acute Sequelae of SARS-CoV-2 Infection (PASC)/RECOVER trial. However, we
fully recognize that our work has only just begun, as we collectively address disparities and improve the
lives of our citizens. It is also apparent, that slowly, but surely, we are impacting public health one
project at a time! With new services proposed and the additional resources that will be added, our
Center is uniquely positioned to devote our activities and resources to our major theme for the next 5-
year cycle that will “address health disparities and improve the health outcomes of the citizens we
serve”

Public health relevance
PROJECT NARRATIVE Clinical presentations of acute COVID-19 and PASC/Long COVID will change in time as vaccinated and unvaccinated patients are infected or re-infected with new variants. Continued participation in N3C and N3C research groups will allow us to enrich the national cohort with large numbers of cases. Our research efforts will identify clinical risk factors and viral variants associated with breakthrough infections, reinfections and the different presentations of PASC/Long COVID, in collaboration with other CTRs and the Veterans Administration.